Investigating the Influences of Sleep‐Wake Patterns and Gut Microbiome Development in Infancy on Rapid Weight Gain, an Early Risk Factor for Obesity

PROJECT SUMMARY
Rapid Weight Gain (RWG; >+0.67 change in weight-for-age Z-score) during the first 6 months of life is a strong
determinant of early life and persistent obesity, and cardiometabolic diseases. Obesity affects 18.5% of American
children aged 2-19 years and 8.1% of those <2 years. While short sleep duration and poor sleep quality are
important early risk factors for the development of childhood obesity and are major targets of national prevention
efforts, their impact on early RWG is less understood. Sleep-wake patterns in infancy, such as the development
of the 24-hr circadian sleep-wake rhythm, an important neurological milestone, may be especially important for
influencing risk of RWG. Disruptions to circadian sleep-wake rhythmicity are associated with greater adiposity
and its development primarily occurs in the first 6 months of life, the same critical, predictive timeframe as RWG.
The human gut microbiome (GM) is also established during this time to promote growth through energy
harvesting and metabolic signaling. Emerging data suggest that sleep may alter the GM and infant metabolism,
which ultimately may impact obesity. To date, most GM research has focused on the independent effects of
vaginal vs. cesarean birth delivery, antibiotic use, and breastfeeding vs. formula feeding on childhood obesity
risk. However, evidence is limited on if sleep-wake pattern and GM development interact to influence RWG.
Broadening our understanding of the GM role in obesity risk in early life to include the establishment of sleep-
wake patterns will improve our ability to intervene at a young age and prevent the onset of obesity. Therefore,
we propose to prospectively follow 192 mother-infant pairs prenatally through 12 months (3 weeks, 8 weeks, and
3, 6, 9 and 12 months) of life and assess the magnitude and timing of infant sleep-wake patterns and GM
development as predictors of RWG. This project will implement a novel conceptual framework that incorporates
the GM and sleep-wake patterns as metabolic contributors for RWG. The underlying theoretical and analytical
framework of this work will be based on the Ecological Model of Growth (EMG) that focuses on child, maternal,
family, and environmental factors that contribute to a child’s growth and combines human ecology and
epidemiology to evaluate broader interactions among these factors that influence child health outcomes. EMG
factors will be included as covariates in models of sleep and GM development on RWG. Our study will address
the following aims: 1- Investigate associations of infant sleep-wake patterns with subsequent RWG at 6 months
and weight gain at 12 months using time-varying effect models; 2- Investigate associations of GM development
with RWG at 6 months and weight at 12 months; and 3- Evaluate whether temporal interactions exist between
infant sleep-wake patterns and GM development, and if these relations influence RWG. Project findings will
inform future clinical interventions that include sleep and GM approaches to reduce the risk of RWG in infancy.
This pipeline of work will ultimately lead to the development of evidence-based guidelines for sleep and GM
development to prevent obesity through the identification of crucial developmental time intervals for RWG.

Public health relevance
PROJECT NARRATIVE Obesity, especially among young children, is a serious danger to the current and future health of America and understanding what personal and environmental factors influence obesity development are crucial to reversing the current obesity epidemic. This study will examine how two understudied factors, sleep-wake patterns and the gut microbiome, affect rapid weight gain in infancy, an early risk factor for obesity. The development of sleep-wake patterns and gut microbe communities will be evaluated, in the context of diverse feeding, maternal, and environmental influences, on infant weight gain.